Indiana University Melvin and Bren Simon Comprehensive Cancer Center Support Grant

ABSTRACT, Overview and Essential Characteristics
The Indiana University Melvin and Bren Simon Comprehensive Cancer Center (IUSCCC) is Indiana's only NCI-
designated Comprehensive Cancer Center and is dedicated to cancer research, education, and patient care for
the residents of Indiana and beyond. Our Vision is that Research Cures Cancer, and our Mission is to create
an expanding community of researchers and health professionals who conduct outstanding research, provide
excellence in education, and deliver high-quality patient-centered care. IUSCCC received an overall score of
“Outstanding” at the last (2018) renewal and achieved Comprehensive status. In the current grant period,
IUSCCC has continued to build on this exceptional foundation of accomplishment. Compared to 2018, there has
been a 24% increase in peer-reviewed funding (17% increase in NCI funding), 53% increase in Team Science
MPI grants, 36% increase in publications (20% in journals with IF>10), and 27% increase in accrual to therapeutic
investigator-initiated trials. With the recruitment of Dr. Kelvin Lee as the third IUSCCC Director in February 2021,
there has been major alignment and integration of IUSCCC's oversight of the strategic direction in cancer service
line efforts (quality and clinical pathways) with research and education across both the IU School of Medicine
and the IU Health health care system. IUSCCC's expertise was recently recognized by being named a member
of the National Comprehensive Cancer Network. We have strategically and substantially increased our
translational research expertise and capabilities, including the development of the Cancer Drug Discovery &
Development Accelerator, Brown Center for Immunotherapy, and Early Phase Clinical Trial Program. Our global
oncology efforts continue to grow with establishment of the Center for Global Oncology and Health Equity. We
launched the new Translational Cancer Biology PhD program based in IUSCCC. We have significantly expanded
the Office of Community Outreach and Engagement and its activities, and elevated the importance of diversity,
equity, and inclusion (DEI) with creation of an Associate Director for DEI in 2021. IUSCCC seeks to continue its
upward trajectory by enabling paradigm-practice-policy-changing research through: 1) providing foundational
organizing capabilities in research infrastructure and shared resources; physical space; institutional alignment,
integration, and resources; transdisciplinary collaboration; DEI; and programmatic and administrative leadership;
2) developing efforts in education, data, informatics, biostatistics, and community outreach and engagement that
integrate internal activities and meaningfully engage our external communities and partners; 3) fostering cancer-
focused research in mechanism-based biology and medicine, BenchBedsideMain Street translational
research, and population health/social determinants research that have significant local and global impact; and
4) training the next generation of diverse cancer researchers, from teens to tenure, through innovative cancer-
focused programs encompassing the basic, clinical and translational, population, and social sciences.

Public health relevance
PROJECT NARRATIVE- OVERVIEW The Indiana University Melvin and Bren Simon Cancer Center is an NCI-designated Cancer Center whose mission is to create an expanding community of researchers and health professionals who conduct outstanding translational research, provide excellence in education, and deliver high quality patient-centered care. We will foster and promote an environment of cultural awareness, diversity, and inclusion as we contribute to the prevention and cure of cancer in Indiana. We recognize social injustices and discrimination exist, and we further our mission by embracing the rich perspectives and experiences that arise from racial, ethnic, socioeconomic, sexual, gender, and religious diversity within our community.